Structural analysis of the human LRRK2

PROJECT SUMMARY
Parkinson’s Disease (PD) is the second most common neurodegenerative disease, featured by movement
disorders. PD affects nearly one million Americans and ten million people worldwide. While aging is the major
risk factor, PD can also be caused by genetic mutations. More than ten PD-associated genes have been
identified, and LRRK2 mutations are the most common cause of both familial and sporadic PD cases. LRRK2
gene encodes the leucine-rich repeat kinase 2 (LRRK2), a large multidomain protein with both kinase and
GTPase activities; most of the LRRK2 disease mutations show increased kinase activity. Therefore, inhibiting
LRRK2 kinase activity holds great potential for treating PD, and numerous pharmaceutical companies are
making tremendous efforts to develop specific inhibitors. Our previous work has revealed the first cryo-EM
structures of full-length human LRRK2, providing the atomic architecture of this 286-kDa kinase in an inactive
conformation. Here we propose to further investigate the working mechanism of LRRK2 by combining cutting-
edge structural biology techniques such as single-particle cryoEM with biochemical, biophysical and cell
biology approaches. We hypothesize that understanding the structural basis of the LRRK2 recruitment,
activation and substrate recognition could provide novel directions for the development of allosteric
inhibitors. In this proposal, the working mechanism of LRRK2 will be dissected at atomic details by
addressing the following fundamental questions. i) How do Rab GTPases recruit LRRK2? ii) What is the
active conformation of LRRK2? and iii) how does LRRK2 specifically recognize its substrates? The
successful outcome of this proposal will provide a molecular picture of the LRRK2 recruitment, activation and
substrate recognition processes in atomic details and, therefore, could serve as the conceptual framework for
designing allosteric LRRK2 inhibitors to treat PD.

Public health relevance
PROJECT NARRATIVE Parkinson’s Disease (PD) is the second most common neurodegenerative disease, affecting nearly one million Americans and ten million people worldwide. This proposal aims to understand how the LRRK2 kinase, mutation of which is the most common genetic cause of PD, works at the molecular level. We believe that the outcomes of our research will provide the conceptual framework for novel drug discovery strategies to combat PD.